Mentoring in Patient-Oriented Neuroscience Research

PROJECT SUMMARY
I am a clinical researcher and Director of the Neurodevelopmental Laboratory on Addictions and Mental Health
at McLean Hospital. I also am an Associate Professor in Psychiatry at Harvard Medical School. I have been
continuously funded as a principal investigator (PI) to conduct NIAAA-sponsored patient-oriented research
(POR) since 2004 and have been a collaborator and consultant on multiple NIH-sponsored grants. My
research focusing on understanding adolescent brain development, and risk for and underlying neurobiology of
addiction and psychiatric disorders. During the first 5-year K24 period, I provided mentoring to 50 individuals
ranging in rank from undergraduates through psychiatry residents and junior faculty. These mentees have
made notable success, including publishing papers, submitting grant applications and being promoted. I work
in a rich environment for clinical research, which is ideal for providing mentoring in POR. As I receive no
institutional support for mentoring and will be required to curtail mentoring efforts to assume significant non-
research responsibilities, a K24 renewal will continue to provide protected time that would allow me to maintain
and increase my intensive mentorship to trainees, and attract new research mentees to POR. My immediate
and long-term career objectives are to continue characterizing neurobiological markers in addiction and
psychiatric disorders, which will inform the development of new and effective treatments for alcohol use
disorders and for individuals with dual diagnoses, and to train the next generation of investigators to develop
the skills they require to effectively conduct POR. I remain committed to disseminating research findings
(through publications, scientific lectures and public outreach) and provide mentoring to trainees in public
outreach, the goal of which is to provide education around alcohol research, which in turn will help prevention
efforts and inform treatment interventions, to aid in the reduction of suffering due to alcohol use and abuse.
The specific aims to be accomplished during the period of the award are to 1) provide substantive mentoring of
junior investigators and trainees in POR (35%), with a focus on mentoring underrepresented minority trainees;
2) continue and extend involvement in my POR (10%), and 3) advance my expertise in the content areas of
adolescent comorbid psychopathology, clinical approaches in adolescent treatment, and conducting research
in vulnerable adolescent and adult populations, including racial/ethnically disadvantaged youth and those
navigating gender identity development, both with established evidence of mental health disparities (5%).
Despite the challenges imposed by the COVID19 pandemic, these mentoring relationships have continued to
grow, and trainees are making significant strides in their paths toward POR. I remain deeply committed to the
continued training of a remarkable group of mentees, who are the future of addiction and psychiatry POR.
Through intensive mentoring I will enhance my POR by increasing my clinical perspectives, and by
incorporating treatment and multicultural considerations into my POR initiatives.

Public health relevance
PROJECT NARRATIVE The primary goals of this K24 renewal application are to enable Marisa M. Silveri, Ph.D., to continue to 1) provide substantive mentoring of junior investigators and trainees in POR (35%), with a focus on mentoring underrepresented minority trainees; 2) continue and extend involvement in my POR (10%), and 3) advance my expertise in the content areas of adolescent comorbid psychopathology, clinical approaches in adolescent treatment settings, and vulnerable populations, including gender and racial/ethnically diverse youth, for which there are significant mental health disparities (5%). The public health importance of this renewal application addresses the need to characterize neurobiological markers in addiction and psychiatric disorders, which will inform development of new and effective treatments for alcohol use disorder and for patients with dual diagnoses, and the need to train the next generation of investigators to develop the skills they require to effectively conduct research with patient populations.